Expansion of the efficacy trial of Tele-Harm Reduction into a federally qualified health center operated syringe services program.

PROJECT ABSTRACT
This application is being submitted in response to PA-20-272 as an administrative supplement to DP2DA053720-
01 (PI: Tookes). The T-SHARP (Telehealth Solution to HIV and Addiction-Related Problems) trial will study the
efficacy of the Tele-Harm Reduction intervention in 2 syringe services programs (SSPs) operated within
academic medical centers, University of Miami/Jackson Health System and University of South Florida/Tampa
General Hospital. The aims of this administrative supplement are 1) to expand the T-SHARP trial of the Tele-
Harm Reduction intervention to a third site in Florida with a high prevalence of PWID with HIV and 2) to examine
implementation barriers and facilitators to identify appropriate implementation strategies to facilitate
implementation of the Tele-Harm Reduction intervention within a new contextual environment (a Federally
Qualified Health Center based SSP). The third site will expand the existing trial to three of the seven Ending the
HIV Epidemic jurisdictions in Florida (Miami-Dade, Hillsborough, and Broward Counties). This expansion of trial
sites and study of the intervention implementation in a new context will ensure the study meets enrollment targets
and that the intervention is feasible in varying SSP environments.

Public health relevance
PROJECT NARRATIVE Tele-Harm Reduction seeks to engage people who inject drugs (PWID) into HIV care by bringing healthcare out of the traditional healthcare system and leveraging syringe services programs as trusted venues to deliver telehealth-enhanced access to antiretrovirals, medications for opioid use disorder, and hepatitis C cure. We urgently need a robust evidence base to prove that Tele-Harm Reduction can help us End the HIV Epidemic in PWID and save lives. We seek to set the foundation to build a new standard of care to treat HIV among PWID in the COVID era and beyond.